Determining the role of neutrophils in anti-tumor immunity and immune-related adverse events in the context of T cell-based therapies

PROJECT SUMMARY/ABSTRACT
Despite recent progress, most patients with solid tumors still do not respond to immunotherapies. Responders
often experience immune-related adverse events (irAEs), which can be life-threatening and require treatment
discontinuation. Current immunotherapies focus on enhancing the fitness of anti-tumor effector T cells, but do
not simultaneously engage innate immune responses. Neutrophils infiltrate tumors and can exhibit either anti-
or pro-tumorigenic properties, depending on the context of tissue inflammation. While chronic inflammation
favors pro-tumorigenic neutrophils, we and others have demonstrated that acute inflammation induced by T cell
therapies promotes anti-tumorigenic neutrophils that help eradicate the tumor. However, it remains unclear how
neutrophils become tumoricidal following immunotherapy. In melanoma, neutrophils also infiltrate healthy tissues
of immunotherapy-responders with irAEs, suggesting potential pathogenic properties. Nonetheless, the direct
contribution of neutrophils to development of irAEs has not been addressed. Understanding these mechanisms
is crucial to develop new combination treatments that activate synergies between the innate and adaptive
immune systems to potentiate anti-tumor responses while preventing immunological toxicities. To investigate the
precise role of neutrophils in anti-tumor immunity and irAEs, we propose:
Aim 1. Characterize gene pathways and tumor-derived factors defining functional subsets of anti-tumorigenic
neutrophils. We will identify key molecular targets underlying neutrophil tumoricidal activity by integrating scRNA-
seq and proteomics across models of anti- and pro-tumorigenic neutrophils. We will evaluate whether these
targets can promote neutrophil-mediated tumor control in preclinical melanoma and breast cancer models. Aim
2. Identify clinically relevant mechanisms of tumor cell destruction employed by neutrophils. We will evaluate the
contribution of known neutrophil killing pathways, including ROS and NETosis, to immunotherapies using genetic
models and inhibitors targeting key mediators of these pathways. We will assess if neutrophils selectively kill
tumor cells. Furthermore, we will evaluate the clinical relevance of gene signatures, molecular cues, and killing
mechanisms in biospecimens from patients with solid tumors undergoing immunotherapies. Aim 3. Uncover the
role of neutrophils in development of irAEs. Preliminary data suggest that neutrophil depletion alleviates skin
immunological toxicities associated with immunotherapy. We will use this model along with scRNA-seq studies
to identify actionable targets that uncouple neutrophil tumoricidal activity from pathogenic behavior and validate
findings in patient samples. We will also evaluate the contribution of VISTA and NETosis to development of irAEs.
We expect to find immunotherapeutic interventions based on innate immune profiles and reliable biomarkers for
cancer prognosis. Our long-term goal is to develop approaches targeting neutrophils that enhance anti-tumor
immunity while preventing associated toxicities to advance the precision and safety of immunotherapies.

Public health relevance
PROJECT NARRATIVE This proposal aims to identify molecular targets defining functional subsets of anti-tumorigenic neutrophils in the context of T cell-based therapies and addressing the role of neutrophils in the development of immune related adverse events (irAEs). By integrating single cell RNA-seq analyses, proteomics studies, in vitro and in vivo assays alongside validating findings in patient samples, we aim to uncover clinically relevant mechanisms driving neutrophil tumoricidal activity while reducing neutrophil-associated toxicities following immunotherapies. Our goal is to develop more effective strategies that activate innate immune responses to synergize with currently approved immunotherapies in order to enhance anti-tumor immunity while preventing irAEs and advance the precision and safety of immunotherapies.